Processing of TGFbeta as a mechanism for precise temporal orchestration in long term memory formation

PROJECT SUMMARY
One of the great challenges of modern neuroscience is understanding the detailed molecular
choreography required for the formation of lasting memories in the brain. At the heart of this challenge lies a
complex network of molecular processes that must be integrated at precise timepoints to create a cellular
environment favorable for long-term memory (LTM) formation. However, the neurobiological processes and the
precise timing of their signaling cascades during LTM formation remain to be fully understood. One family of
molecular processes that could contribute to the temporal requirements for LTM formation is growth factor (GF)
signaling. GFs, canonically viewed as regulators of developmental plasticity, are becoming widely appreciated
as key mediators of synaptic plasticity and memory in adults. Recent findings from our laboratory show that a
specific GF, transforming growth factor beta (TGFβ), provides a unique mechanism that plays a major role in
the temporal processing underlying LTM. This project will test the novel hypothesis that TGFβ’s signaling
cascade can act as a “molecular timekeeper” through the integration of its activity, contributing to the temporal
computations necessary for LTM formation. To this end, I will examine three distinct components of the TGFβ
signaling cascade during LTM: (i) TGFβ-ligands, (ii) TGFβ-receptors, and (iii) downstream mediator proteins, to
determine how each component uniquely contributes to the temporal processing necessary for LTM formation.
In Aim I, I will examine how synthesis and/or release of TGFβ-ligands could each be key events whose timing
is necessary for LTM formation. In Aim II, I will study how TGFβ ligand activation, through proteolysis and
changes at the level of TGFβ-receptors, may be critical time-keeping events. Finally, in Aim III, I will assess
whether TGFβ-initiated intracellular singling via Smad proteins is necessary for LTM formation. For all
experiments, I will use a powerful paradigm developed to study LTM in the marine mollusk Aplysia. This
paradigm induces LTM for sensitization after only two trials, but only if the trials are separated by a specific,
highly constrained time window of 45 minutes. This minimal system separates the initiating stimulus (Trial 1)
from the repeated stimulus (Trial 2), providing unparalleled access to the specific temporal interactions
underlying LTM formation. Finally, this project has the potential to contribute significant impact from a clinical
perspective, as these findings will have direct implications for understanding human memory formation under
healthy conditions and when compromised in neurological disease. Since TGFβ’s signaling cascade has been
implicated in the pathogenesis of many of these neurological disorders, understanding when and how TGFβ
acts in the brain during memory formation could provide novel avenues for developing more effective and
targeted therapeutics.

Public health relevance
PROJECT NARRATIVE Long term memory (LTM) formation requires finely tuned choreography of complex molecular signaling processes, many of which are compromised in neurological and neurodegenerative disorders. Growth factors, which have canonically been viewed as orchestrators of development, have recently been implicated in the regulation of synaptic plasticity and memory in adults. This project will investigate the time keeping aspects of transforming growth factor beta (TGFβ) as an essential component of the cellular computations necessary for LTM formation.